Administrative Core

PROJECT SUMMARY FOR ADMINISTRATIVE CORE
The Administrative Core provides the leadership and governance to maximize the impact of the highly
successful UCSF-Bay Area CFAR, one of the original CFARs funded by NIAID in 1988. We note the
publication of 701 papers citing the CFAR in the past 4 years and the securing of over $400 million in
HIV-related NIH funding across our CFAR. The former leadership led a productive CFAR and a thoughtful
succession process to new leadership in 2019. New leadership then strategically reconfigured the CFAR
by introducing new components and enhancing existing ones to expand our reach. Of the 151 projects
on our funded research base, CFAR provided direct service to 52 (34%) and was connected to 133 (88%).
With our expanded initiatives in the reconfigured UCSF Bay Area CFAR, we increase direct services to 96
(64%) projects, with 142 (94%) receiving support. The Administrative Core propels new multidisciplinary
research, ensures community engagement and health equity, and furthers scientific exchange.
Informed by robust strategic planning and program evaluation processes, the Core will organize and
oversee all CFAR components to ensure that the CFAR is responsive to the needs of our research community
while continuing sound fiscal management of Center resources. Moreover, the Administrative Core will
ensure focus of the CFAR on our three cross cutting areas of health equity and community
engagement, training, and international research via four aims: 1) Convening a collaborative CFAR
community by providing opportunities for productive scientific exchanges, maintaining bidirectional
communications between CFAR leadership and members, and promoting internal and external collaborations;
2) Providing effective and responsible institutional leadership to leverage CFAR and institutional resources by
connecting CFAR investigators to CFAR/institutional resources and HIV research opportunities, securing input
from internal and external advisory sources to improve the CFAR, and repositioning CFAR resources as
needed; 3) Engaging the communities we serve to inform CFAR activities and extend its impact by enhancing
our collaborations with local health departments and Getting to Zero consortia in San Francisco and the East
Bay, hosting our annual Bay Area Health Disparities Symposium, supporting collaborations with local
community-based organizations, and co-organizing our joint Community Advisory Board; and 4) Monitoring
and evaluating the success of CFAR programs to drive effective strategic planning and decision making by
continuing rigorous financial/regulatory management, ensuring that CFAR activities are responsive to the
Office of AIDS Research HIV priorities, convening our Core Management Committee, and measuring the
success of Scientific and Developmental Cores, programs and the Scientific Working Groups.